HIV and Other Infectious Consequences of Substance Abuse

PROJECT SUMMARY This is the third competitive renewal for T32DA013911 (“HIV and Other Infectious Consequences of Substance Abuse”) and seeks funding for Years 2017-2022. The program will now be led by dual PIs: Dr. Timothy P. Flanigan (the PI for the past 15 years), who will direct mentoring and training, and Dr. Josiah D. Rich, who will direct research project development. This training grant focuses on applied clinical and substance use research in Rhode Island and beyond. Rhode Island has among the highest rates of substance use in the nation and ranks 6th in the country for overdose rates. Our substance use training program emerged from the Brown University-affiliated Miriam Hospital Immunology Center, the largest HIV care center in Southern New England, where approximately 60% of the patients engage in substance use (alcohol, cocaine, opiate, methamphetamines, and poly-substance abuse). Our program's strengths are our interdisciplinary collaborations to reduce the infectious disease consequences of substance use, including HIV, hepatitis B and C, sexually transmitted infections, and TB. This training program brings together core expertise from the Division of Infectious Diseases, the Providence-Boston Center for AIDS Research (CFAR), the Centers for Behavioral and Preventive Medicine, the Brown University Center for Statistical Studies, and the Brown University School of Public Health. This interdisciplinary training program focuses on HIV prevention and treatment, including innovative PrEP programs, and correctional health, with a primary focus on reducing the infectious consequences of substance use as well as overdose. Our mentors have strong track records in applied clinical, substance use, translational science, correctional health research, and community-engaged scholarship.

Public health relevance
PROJECT NARRATIVE This program trains post-doctoral fellows in clinical research to more effectively understand and manage the challenges of HIV and other infectious consequences of substance abuse. Incorporating expertise from multiple disciplines greatly enhances diagnosis, prevention and treatment research of HIV and other infectious diseases among active substance abusers and within communities that are heavily impacted by substance abuse. Community engagement is emphasized to ensure that marginalized communities benefit from advances in biomedical science.